Kean University U-RISE Trainee Pathway (KUTP)

ABSTRACT
Kean University is a minority-serving institution with over 16,000 students. The Kean School of Integrative
Science and Technology (IST) serves roughly 2,100 students, 55% from groups underrepresented in the
sciences. The IST offers undergraduate honors programs in science and provides an interdisciplinary lens
recognizing the convergence of scientific traditions across key fields of study. It is an ideal home for the proposed
U-RISE program, the Kean University U-RISE Trainee Pathway (KUTP).
The KUTP will have a significant impact on Kean’s ability to train undergraduates in research excellence, unite
them in a diverse cohort to build the social capital underlying STEM identity, and prepare them for the next phase
of the biomedical research career pathway. KUTP recruitment will draw upon the IST’s extraordinary Group
Summer Scholars Research Program for high-school students, a STEM Push Program, as well as Kean’s Office
of Diversity, Equity, and Inclusion. KUTP will ultimately serve a steady-state total of 20 fellows across the fields
of biology, biomedicine, biotechnology, chemistry, computer science, mathematics, and integrated science, for
a total of 54 fellows over the five-year program. Fellows will receive financial support, intensive triad mentoring,
and rigorous academic and research-skills training. The KUTP will expand on the IST’s existing strengths by
adding advanced training in the responsible conduct of research and new cohort activities to increase the sense
of belonging, self-efficacy, and STEM identity of undergraduates. KUTP fellows will participate in more advanced,
independent research projects and professional development activities fostered by Kean faculty, collaborators
at the Northeast Alliance for Graduate Education and the Professoriate (with members from Amherst, Boston
University, MIT, Penn State, Rutgers, MIT, UNH, UMass, and other regional schools), and industry professionals
at the Institute for Life Science Entrepreneurship (ILSE), a regional NYC/NJ metro area incubator, accelerator,
and research institute located on the Kean campus. Drawing on Kean’s extensive expertise in the training of
underrepresented minorities, the KUTP incorporates data-driven mechanisms to create sustainable
programmatic experiences and establish a model that can be applied more broadly at Kean and other institutions.
Program objectives are to increase recruitment, diversity, retention, and persistence for biomedical and related
majors at Kean, with 100% of KUTP fellows graduating and 30% and 15% of graduating KUTP fellows entering
MS-level and PhD-level programs, respectively, in biomedical and related fields within three years of graduation.
Kean will sustain the KUTP beyond the grant period and disseminate its results to other institutions.

Public health relevance
PROJECT NARRATIVE The Kean University U-RISE Trainee Pathway will expand and enhance recruitment and training of undergraduate students in the conduct of rigorous, responsible research in biomedical fields. The goal is to increase the diversity and number of students graduating with bachelor of science degrees, entering and graduating from PhD programs, and joining the research workforce. Strengthening the biomedical research workforce will speed medical progress, ultimately improving healthcare for all.